Novel Mechanisms of CD4-Independent Immunity Against Pneumocystis

Pneumocystis pneumonia (PCP) remains a serious life-threatening respiratory fungal infection of
immunocompromised patients, and one of the most common AIDS-defining illnesses in the US and the
world. PCP-related mortality rates have changed little over the past two decades, likely due to our inability to
adequately treat the infection without exacerbating immunopathogenesis. Adjunctive corticosteroids are used to
suppress inflammatory injury during antibiotic treatment, but the benefit of these broadly acting agents is
uncertain. The mechanisms by which Pneumocystis (PC) is recognized and cleared from the lung remain
incompletely understood. Alveolar macrophages (AMs) are important effectors of pulmonary innate immunity,
but they are typically ineffective for host defense against Pneumocystis when CD4+ T cell help is not fully
functional. The reason for this is unknown, but it has been suggested that PC actively evades or suppresses
macrophage mediated host defense to ensure survival and transmission. Our laboratory has identified an inbred
mouse strain which is unique in that it displays robust and rapid innate immunity against PC in the absence of
CD4+ T cell function. The resistant phenotype requires AM-dependent removal of PC, but the specific mechanism
remains unknown. In vitro studies have failed to reveal distinct differences in the phagocytic potential of resistant
and susceptible AMs, leading us to hypothesize that the lung environment and lung epithelial cells (LECs) are
critical components of effective innate immunity against PC. To test this hypothesis, we will utilize the resistant
and susceptible mouse models described in our preliminary studies. Our long-term goal is to identify the effector
mechanisms responsible for FVB protective innate immunity. We predict that the robust and rapid removal of PC
from the lungs of FVB mice suggests that once identified, this mechanism might be exploited to design novel
strategies that quickly eradicate PC without eliciting immunopathogenesis, providing improved outcomes in HIV
and other patients with compromised CD4+ T cell function. In order to advance this goal, we propose two Specific
Aims that will: 1) define the early transcriptional profiles of resistant (FVB) and susceptible (Balbc) LECs following
the in vivo interaction with PC; and 2) directly determine whether the FVB lung environment, including LECs, is
required for effective innate immunity against PC. If the proposed hypothesis is correct, these studies could drive
new directions of research into the mechanisms that regulate pulmonary innate immunity.F2

Public health relevance
By exploring novel mechanisms regulating the effectiveness of pulmonary innate immunity, this proposal has the potential to identify new therapeutic targets to control fungal growth. This approach will help address the decades-long failure to make major improvements in the outcome of PCP. The goal of this project is directly responsive to the NIH mission statement of the need to generate basic science data that can be developed into translational studies designed to improve patient care.